Rationally-designed modulators of the a-beta aggregation cascade

P2 - ABSTRACT The misfolding and aggregation cascade of the Aβ polypeptide is widely accepted to be the root cause of Alzheimer's disease (AD). However, the development of agents that are able to alter the misfolding and aggregation cascade has proven difficult. Small molecules are generally unable to present sufficiently large interaction surfaces to compete with the protein-protein interactions that drive aggregation, while antibodies are difficult to direct against specific conformational or oligomeric states. An alternative is the rational, computer- aided design of proteins and peptides that are able to bind specifically to particular species in the Aβ misfolding and aggregation cascade, and which can alter this process in well-defined ways. We propose to develop agents able to alter Aβ misfolding and aggregation in three ways, each representing a different possible strategy for mitigating Aβ neurotoxicity. First, we will create small proteins that are able to bind specifically to monomeric Aβ that has not yet entered the aggregation cascade, sequestering it or directing it for clearance or degradation. Second, we will create peptides able to cap growing Aβ amyloid fibrils to block fibril elongation, shifting the Aβ population to soluble species that can be cleared by other mechanisms. And third, we will create fibril-coating proteins that are able to stabilize pre-formed Aβ amyloid fibrils and prevent the dissociation that can produce toxic, soluble, oligomeric species. The peptides and proteins produced will be useful experimental agents for testing different AD treatment strategies, based on several different hypotheses of Aβ toxicity, in model systems.